Unraveling gut-microbiome-brain interactions in neurodevelopmental disorders

PROJECT ABSTRACT
Most of the current focus in neurodevelopmental disorders (NDDs) research has been based on identifying key
brain regions, relevant signaling pathways and selective brain circuits that give rise to overt behavioral and
internal neuronal states Interestingly, we have recently found that that specific gut microbes can modulate brain
function and behaviors in an amazingly powerful way via the gut-brain axis. Here we will combine state-of-the-
art transcriptomics, metabolomics, pharmacology, microbiology, genetics, metagenomics, electrophysiology and
behavior to identify the mechanism(s) by which a gut microbe (L. reuteri) reverses the social deficits in NDD
mouse models. Briefly, we will define the molecular and genetic mechanism by which L. reuteri and L. reuteri-
induced metabolites promote social behavior and related changes in synaptic function. In addition, we will identify
the mode of gut-brain communication (‘gut-brain axis’) by which L. reuteri and L. reuteri-induced metabolites
modulate brain function and behavior. Finally, we will assess the broader therapeutic potential for L. reuteri-
induced metabolites in different models for NDDs with social dysfunction. Our findings could not only provide a
new holistic dimension of how behaviors and the brain are controlled by gut microbes, but they could also lead
to the development of new non-invasive microbial-based therapies for NDDs.

Public health relevance
PROJECT NARRATIVE The gut microbiome is emerging as key regulator of complex behaviors, including those associated with neurodevelopmental disorders, but little is known about the underlying mechanism. Here, we will use a series of multidisciplinary and convergent approaches to identify the signals, structures and mechanisms by which a given bacterial species (L. reuteri) regulates a selective behavior (social behavior). We believe that these studies could lead to the development of novel probiotic-based non-invasive treatments for individuals with neurodevelopmental disorders associated with social deficits.